Exploring Functional Divergence in Human and Chimpanzee Arteries: Implications for Cardiovascular Disease

PROJECT SUMMARY/ABSTRACT
Atherosclerotic cardiovascular disease is the leading cause of death worldwide and its rates are rapidly
rising, especially in the developing world. Despite decades of research, many questions remain about the
disease’s cellular and molecular processes. Chimpanzees, the closest living relative of humans, are not as
susceptible to atherosclerosis, despite having higher serum cholesterol levels. This divergence in disease
susceptibility between closely related species provides a novel approach to study atherosclerosis. To study these
species-specific changes, I will utilize recently published human-chimpanzee hybrid cell lines, a system that
allows for the precise detection of species-specific gene expression changes. These cells will be used in
conjunction with a protocol that allows for the creation of pure populations of arterial endothelial cells (aECs)
from induced pluripotent stem cells. Using the hybrid cells, I have already identified several candidate pathways
which exhibit species-specific gene expression changes in aECs. In aim 1, I will assay the function of aECs from
both species and identify novel phenotypic differences between human and chimpanzee arterial
endothelial cells. These disparities could provide insights into developmental differences as well as provide
clues to atherosclerotic mechanisms.
Inflammatory signals are thought to drive atherosclerosis and my preliminary data shows differences in
gene expression between species following exposure to inflammatory cues. In aim 2, I will identify gene
expression divergence between species by subjecting hybrid cells to stimuli that mimic an atherosclerotic
environment. By measuring species-specific expression changes in various conditions, I can catalog the genes
that are differentially regulated upon exposure to atherosclerotic stimuli, to provide clues about disease
pathology. These changes in gene expression will need to be functionally validated to demonstrate that they can
influence atherosclerosis susceptibility or progression. In aim 3, I will use pharmacological and genetic methods
to interrogate the results from aim 2 to discover novel pathways and genes that influence atherosclerosis.
By forming aECs with human, chimpanzee, and hybrid cell lines and dissecting their phenotypes, new insights
will be gained into the pathways and genes that are atheroprotective in chimpanzee. Furthermore, my findings
will provide a new framework to model the development of atherosclerosis, which may one day be leveraged
into novel therapeutic strategies.

Public health relevance
PROJECT NARRATIVE The factors that induce atherosclerotic cardiovascular disease, the leading cause of death worldwide, are not fully understood despite decades of research. Study of our closest living relative, the chimpanzee, could provide novel insights into the mechanism of this disease as they rarely develop atherosclerotic lesions despite having higher serum cholesterol levels. I intend to use two newly developed methods to create arterial endothelial cells from human, chimpanzee, and human-chimpanzee hybrid cells to investigate species-specific changes in gene expression that may underlie differences in the pathogenesis of atherosclerosis.